Parental Co-Exposure to Methylmercury and Inorganic Arsenic in Zebrafish (Danio rerio): Metabolism and Offspring Behavior

Summary
Methylmercury (MeHg) is a potent neurotoxin, and recent studies indicate that inorganic arsenic(III)
(iAs) is also neurotoxic. Although chemicals co-occur in the environment, the study of chemical mixtures is
more recent. Heavy metals target the central nervous system, and co-exposure may result in synergistic
neurotoxic impacts. However, the biological and molecular mechanisms underlying these joint effects are
uncertain. The aim of our study is to investigate synergism between iAs and MeHg, using the zebrafish (Danio
rerio) model system. Aim 1. Investigate the uptake and metabolism of iAs and MeHg in zebrafish. We
anticipate that co-exposure to both chemicals will alter the proportion of arsenic species in the liver, compared
to controls. Adult zebrafish will be exposed to environmentally relevant levels of MeHg (through diet) and
sodium arsenite (through water) (six treatment groups). In the liver, mercury species and arsenic species will
be compared between treatment groups, and sex-specific differences will be investigated. Accumulation of
mercury and arsenic in adult tissues and organs will be visualized using laser ablation-ICP-MS. Aim 2.
Determine the impacts of MeHg and iAs exposure in progeny, including neurobehavioral outcomes, and
mechanisms of toxicity. Mercury and arsenic species will be determined in whole embryos [120 hours post
fertilization (hpf)], exposed to both neurotoxicants through maternal transfer. In embryos (6-120 hpf) and adults
[90 days post fertilization (dpf)], morphological and neurobehavioral endpoints will be assessed. Using RNA
sequencing, we will conduct genome-wide transcriptomics of offspring brains (90 dpf), and identify signaling
pathways, which are enriched or depleted due to co-exposure. Transcriptomic results will be compared
between treatment groups and males/females. This study will advance our understanding of the mechanisms
by which co-exposure to two chemicals, which frequently co-occur in the environment, contribute
synergistically to offspring neurotoxicity.

Public health relevance
Narrative Methylmercury is a potent neurotoxin, and recent studies indicate that inorganic arsenic is also neurotoxic. This study will advance our understanding of the mechanisms by which co-exposure to two chemicals, which frequently co-occur in the environment, contribute synergistically to offspring neurotoxicity.